ASGCT Annual Meetings 2022-24: Travel Awards and Underrepresented Minority Travel Awards

American Society of Gene and Cell Therapy
PA-21-151
PROJECT SUMMARY
This application by The American Society of Gene and Cell Therapy (ASGCT) requests $15,000 for
10 travels award and 20 underrepresented minority travel awards ($500 per award) for students and
post-doctoral fellows to attend the ASGCT Annual Meetings in 2022, 2023, and 2024—for a total of
$45,000 and 90 travel awards. To determine awards, ASGCT run a report from our abstract
presenter database that pools abstract applicants who are students or post-doctoral fellows. Those
with the top 15 scoring abstracts receive an Excellence in Research Award (not supported by this
grant), and those scoring over 3.5 receive a $500 travel award (such as those supported by this
grant). Then, remaining applicants who identify as underrepresented individuals are ranked by score,
and the top 20 are given travel awards (also to be supported by this grant). ASGCT abides strictly by
the NIH’s definition of underrepresentation populations in selecting awardees.
ASGCT’s mission is to advance knowledge, awareness, and education leading to the discovery and
clinical application of genetic and cellular therapies to alleviate human disease. This project bolsters
our mission by supporting early-career professional to travel to our Annual Meetings to gain
exposure for their research, thereby advancing knowledge and spurning professional development
that will better position those early-career professionals to make discoveries and produce clinical
applications in the future.

Public health relevance
American Society of Gene and Cell Therapy PA-21-151 PROJECT NARRATIVE This project facilitates the professional development of early-career professionals by supporting their travel expenses to our Annual Meeting to present their abstracts. The strength of the scientific early- career professional workforce is essential to the field’s future discoveries and clinical developments. Gene and cell therapy stands at the forefront of treating major chronic and rare diseases, and therefore, fortifying the future experts of the field is highly beneficial to enhancing public health and treating disease.